Role and regulation of a differentiation-specific keratin in keratinocyte adaptation to mechanical stress

Abstract
Skin epithelia provides a multimodal barrier that protects us against the external world, essential for water
retention, mechanical protection, sensory perception, and immune surveillance. Skin on the ventral aspect of the
feet and hands, known as palmoplantar or glabrous skin, bears higher mechanical stress in daily life; however,
the cellular and molecular components that convey mechanical resilience in this specialized tissue are only
partially understood. As an adaptation to the unique stresses it experiences, the epidermis of palmoplantar skin
maintains an intricate pattern of keratin protein expression. Keratins are intermediate filament (IF) forming
proteins whose expression patterns are tightly regulated in response to developmental stage, differentiation, and
stress in epithelial tissues. Importantly, the type I keratin 9 (KRT9/K9) is specifically expressed, at high levels, in
differentiating keratinocytes of the epidermis in human and mouse glabrous skin. The type 1 keratin 16
(KRT16/K16), associated with damage response in interfollicular epidermis, is also constitutively expressed in
the glabrous skin. Mutations in both KRT9/K9 and KRT16/K16 are associated with the formation of palmoplantar
keratoderma (PPK), characterized by hyperkeratosis of the glabrous skin. KRT9/K9 mutation patients develop
epidermolytic PPK, with tissue fragility and cell lysis observed in the suprabasal layers of the glabrous epidermis.
Krt9-/- mice, available in the Coulombe lab, recapitulate the EPPK phenotype. However, despite the clear
importance of Krt9/K9 in maintaining the homeostasis and mechanical integrity of the glabrous epidermis, recent
work in the Coulombe lab, including data in this proposal, suggest that Krt9/K9 is undetectable on the protein
level and extremely low on the mRNA level immediately prior to birth in mice. This is temporally uncoupled from
the expression of Krt9/K9’s type 2 partner, keratin 1 (Krt1/K1). Additionally, data in this proposal shows aberrant
nuclear-localized Yap1 in the suprabasal layers of the lesional glabrous skin of Krt9-/- mice, suggesting a potential
role for Krt9/K9 in regulating the mechanosensitive Hippo signaling pathway in the glabrous epidermis. In this
study, I aim to define the role and regulation of Krt9/K9 in response to stress in the developing
palmoplantar skin. I hypothesize that Krt9/K9 is responsive to mechanical stress signals, particularly the
expression of Krt16/K16, and maintains the homeostatic balance of the glabrous epidermis via negative
regulation of mechanosensitive signaling pathways, such as Hippo signaling. Completion of this work will
illuminate critical mechanisms by which the keratinocyte differentiation program adapts to physical stresses, as
well as provide insight into the pathogenesis of many keratin-linked diseases which manifest at the sites of
mechanical stress.

Public health relevance
Project Narrative The palmoplantar or glabrous epidermis is uniquely adapted to the greater mechanical stress it experiences in daily life, as compared to other body sites, and is characterized by a specific pattern of keratin intermediate filament (IF) expression including the glabrous-specific keratin 9 and the stress-inducible keratin 16. Keratin 9 levels are remarkably low in embryonic mice, despite abundant expression in adult mouse and human glabrous skin, and mice lacking keratin 9 develop thick glabrous lesions. This proposal will identify the temporal and spatial dynamics and role of keratin 9 expression during early postnatal life and investigate the contribution of mechanical stress, specifically tension and compression, to homeostasis in this unique epidermal location.